WISDOM: A platform to optimize subtype-specific screening and prevention

The WISDOM Study, that includes 45,000 women in the US, is the first large-scale study of a risk-based
approach to breast cancer screening. Its goal is to determine if risk-based screening is as safe, less morbid
and preferred by women. The ‘WISDOM 1.0’ cohort, enrolling since 2016, began with a risk model that
integrates clinical risk factors, race/ethnicity, breast density, polygenic risk score (PRS), and sequencing for
moderate- and high-penetrance germline mutations.
However, in the past 7 years there have been significant advances in breast cancer risk assessment, such that
we have models that, for the first time, allow us to predict the type of cancer a woman is likely to develop.
Breast cancer is not one disease and women have different risk factors. Thus, it is the hypothesis of this P01
that tailoring screening and prevention recommendations to an individual’s risk as well as the type of cancer for
which she is at risk, can improve the efficacy and efficiency of breast cancer screening, improve the healthcare
value of screening and ultimately reduce breast cancer mortality, incidence, and screening burden.
The four Projects proposed represent a comprehensive research program to advance the science and
evaluation of subtype-specific risk-based breast cancer screening and prevention. In Project 1, we extend
enrollment of the WISDOM Study for 5 years, applying a subtype-specific risk assessment and screening that
delineates risk for fast-growing and slow-growing cancers, and assigns commensurate screening and
prevention recommendations. An additional 50,000 women will be enrolled via an expanded site network.
While Project 1 evaluates our initial fast vs. slow-growing risk models, Projects 2 and 3 will work to improve
subtype risk assessment in two ways, utilizing 5 large, diverse study cohorts with >200,000 women and
>14,000 breast cancer cases, with available imaging and germline data. Project 2 aims to develop improved
PRS for subtype-specific breast cancer risk, building on our preliminary predictor of fast-growing cancer.
Project 3 will apply deep-learning artificial intelligence models for subtype-specific risk based on 2D and 3D
mammographic imaging, and integrate with PRS from Project 2. Project 4 will take the best integrated subtype-
specific risk models and associated screening strategies from Project 3 and determine their impact on the
efficiency and efficacy of screening and prevention of slow growing cancers. We will work in collaboration with
the well-established MISCAN/CISNET modeling team to determine the potential impact for individuals as well
as the population of women in the US. The goal is to find the optimal risk classification schema, based on
reduction in cancer death as well as screening’s potential harms and improvement in overall healthcare value.
Our long-term goal is to iteratively reduce breast cancer mortality, while demonstrating that the WISDOM study
can ultimately serve as a continuous quality improvement platform for breast cancer screening and prevention.
Four cores support this extraordinary effort to bring smarter screening to women in the US.

Public health relevance
OVERALL: NARRATIVE The WISDOM Study, opened in 2016, is the first large clinical trial of a new, personalized approach to breast cancer screening in which women receive individualized screening recommendations based on their personal risk for breast cancer. While our initial efforts were focused on showing that personalized screening was as safe, less morbid, preferred and more likely to result in uptake of preventive strategies in comparison to annual screening, we will now focus on using advances in polygenic risk models and mammographic AI to improve our ability to predict risk for developing fast or slow growing breast cancer subtypes, and tailoring screening and prevention strategies accordingly. Four closely integrated projects will enable us to work toward the goal of a personalized breast cancer screening program that is more effective and efficient, and more likely to help find serious breast cancers early, when they are more likely to be treated successfully, and decrease the incidence of slow growing cancers.